Administrative Core

PROJECT SUMMARY
The P30 Vision Core was established in 1985, and continues to be an invaluable resource to all UCSF vision
scientist investigators. Over the years it has provided critical resources and services that could not have been
supported by individual laboratories. The Cores have evolved over the years based on the changing needs of
the community and continues to offer cutting edge technologies, services and equipment to all UCSF vision
investigators.

Public health relevance
PROJECT NARRATIVE The P30 Vision Core was established in 1985, and continues to be an invaluable resource to all UCSF vision scientist investigators. Over the years it has provided critical resources and services that could not have been supported by individual laboratories. The Cores have evolved over the years based on the changing needs of the community and continues to offer cutting edge technologies, services and equipment to all UCSF vision investigators.